Assessing Patient-Centric Factors and Enhancing Risk Communication to Improve Treatment Persistence in Kidney and Cardiovascular Care

ABSTRACT
Sodium glucose cotransporter 2 inhibitors (SGLT2i) and glucagon-like peptide 1 receptor agonists
(GLP1RA) are two classes of medications poised to revolutionize chronic kidney disease (CKD) care after
repeatedly demonstrating their ability to prevent cardiovascular disease (CVD) and CKD progression in clinical
trials. With pleiotropic benefits across type 2 diabetes mellitus (T2DM), CKD, and CVD, these medications are
the central therapeutic elements of an ongoing shift in CVD prevention from disjointed risk factor control toward
comprehensive, multi-organ care for Cardio-Kidney-Metabolic (CKM) syndrome. This new CKM approach
holds great promise for mitigating the CVD risk that threatens over 14 million adults with T2DM and CKD within
the U.S.; however, prior work from our group and others indicates that the adoption of SGLT2i and GLP1RA in
CKD care is being tragically limited by poor treatment persistence.
Achieving the full benefit of these medications will require novel approaches to motivate and reinforce their
persistence; however, such undertakings in individuals with T2DM and CKD can be challenging — many are
unaware of their diagnosis, providers underestimate their CVD risk, and the unique benefit of these
medications may not be fully appreciated among the myriad of other clinical problems that arise in this
medically complex, high-risk population. To tackle this enormous challenge, the proposed project will rigorously
develop an effective Risk Communication Aid to translate individualized CVD risk estimation and the benefits of
SGLT2i and GLP1RA treatment into joint patient-provider efforts to prevent CVD through persistent treatment.
We will accomplish these goals by first investigating how the complexity of care in persons with T2DM and
CKD is associated with persistent SGLT2i and GLP1RA use across a national integrated health care system
using detailed clinical data from the Veterans Health Administration (VHA) (Aim 1). Then, interviews of patients
and providers across the landscape of CKM care will contextualize insights from Aim 1 by pinpointing key
barriers to persistent treatment using an implementation science framework (Aim 2). Finally, the knowledge
gained from Aim 2 and an iterative, stakeholder-driven development process will be used to create a novel
CVD Risk Communication Aid to facilitate patient-provider discussions promoting persistent SGLT2i and
GLP1RA use. This tool will be piloted in the primary care setting among persons with T2DM and CKD (Aim 3).
This proposal will leverage the unique advantages of VHA to develop innovations in healthcare delivery
that are minimally influenced by costs to patients. Dr. Ikeme has assembled an unparalleled team of mentors
with expertise in CVD risk prediction, innovative kidney care delivery, implementation science, risk
communication, and biostatistics. With their guidance, this work will place Dr. Ikeme at the forefront of effective
CVD prevention in CKD and lay the foundation for an independent R01-level project evaluating a Risk
Communication Aid to improve the persistence of CVD preventive treatment in CKD.

Public health relevance
PROJECT NARRATIVE Sodium glucose cotransporter 2 inhibitors (SGLT2i) and glucagon-like peptide 1 receptor agonists (GLP1RA) are the central therapeutic elements of an ongoing shift toward multi-organ Cardio-Kidney-Metabolic care for cardiovascular prevention, however, their use in chronic kidney disease (CKD) is tragically limited by poor treatment persistence. This proposal aims to use mixed methods to obtain insights from stakeholders that will contribute toward the development of an effective Risk Communication Aid incorporating individualized cardiovascular risk estimation to improve persistence of SGLT2i and GLP1RA in persons with type 2 diabetes and CKD. The final product will be piloted in a primary care setting with the hope of optimizing preventive treatment in this population with high risk of cardiovascular events.